San Diego Resource Center for advancing Alzheimer's Research in Minority Seniors (ARMS)

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core (AC) will provide administrative and intellectual leadership to implement the theme of
the San Diego Resource Center for advancing Alzheimer’s Research in Minority Seniors (SDRC-ARMS). The
theme is: To advance transdisciplinary research on Latino Alzheimer’s Disease and Related Dementias
(ADRD) to illuminate the role of biological, behavioral, sociocultural and environmental factors in
the etiology and outcomes of Latino ADRD. The AC will also coordinate the proposed training activities, and
communications and activities between the PIs, the Core Leaders and Core Members, the AD-RCMAR
Scientists and their mentors. Further, the AC will connect with the larger UC San Diego (UCSD) and San Diego
State University (SDSU) research communities, the UCSD’s Altman Clinical and Translational Research
Institute (ACTRI), the Alzheimer’s Disease Cooperative Study (ADCS), and the Shiley-Marcos Alzheimer’s
Disease Research Center (ADRC), as well as UCSD and SDSU institutional administrative personnel and NIA
staff. The result will be a true transdisciplinary partnership between one of the nation’s leading research
institutions (UCSD) and a research-prolific ‘Hispanic Serving Institution’ (SDSU).